Analyzing Retinal Microanatomy in Retinopathy of Prematurity to Improve Care

PROJECT SUMMARY
As an increasing percentage of preterm infants survive worldwide, the number of infants at risk for retinopathy
of prematurity (ROP) is increasing. These infants are also at high risk for future abnormal visual function and
neurodevelopment. While current screening approaches address identifying eyes for treatment of severe ROP,
there are no attempts to address the later subnormal vision of many preterm infants. In part, this is due to a lack
of information about the retina beyond that of retinal vascular development. In addition, the most common
method to screen for ROP remains indirect ophthalmoscopic examination by physicians with annotated drawings
for documentation, a method proven to be poorly reproducible and stressful to the fragile infant. Bedside retinal
photographs enable documentation and the possibility for telemedicine approaches, but lack information about
retinal microanatomy, are poor quality in darkly pigmented eyes and also are stressful to the infant because of
the required light exposure. We need an infant-friendly, more practical approach to evaluate ROP efficiently and
additional information about ocular and neurovascular development that could lead to improved clinical care.
This research builds on our group’s ability to reliably capture and process non-contact, infrared optical coherence
tomography (OCT) and OCT-angiography of retinal microanatomy and microvasculature at high speed, across
a wide field of view, and at the bedside in preterm infants. Our overall objectives are threefold: first, to evaluate
infant microanatomy and microvascular flow findings relevant to vision and neurodevelopmental outcomes in
children; second, to translate and test our imaging achievements for real-world use by nurses at the bedside and
better clinical insight and feedback; and third, to gather additional data in eyes that progress to treatment and
dive deeper into the insight that they provide into pathways of disease in ROP. The investigational OCT imaging
will be used in this research to gather information that is otherwise not accessible to the physician. This research
will lay the groundwork for future use of infant OCT markers to guide care.

Public health relevance
PROJECT NARRATIVE Retinopathy of prematurity (ROP) is a disorder of development of the neural retina and its vasculature that can impact vision in vulnerable preterm neonates for a lifetime. This study utilizes high-speed optical coherence tomography (OCT) technology at the bedside of very preterm infants in the intensive care nursery, to characterize previously unseen abnormalities that can lead to poor visual development or can be indicators of poor neurological development. Our long-term goal is to help improve preterm infant health and vision via objective bedside imaging and analysis that characterizes early critical indicators of ROP and its response to treatment, poor visual function and neurological development, which will rapidly translate to better early intervention and improved future vision care.